Cancer Center Administration

ABSTRACT – ADMINISTRATION
The administration of the Lurie Cancer Center (LCC) supports the Director, Senior Leaders, Program Leaders,
Shared Resource Directors/Managers, external advisory board members, donors and general membership in
advancing LCC’s mission through administrative management, centralized services and overall planning and
evaluation. As a matrix center, the LCC Adminstration supports key faculty and staff involved with the CCSG
and its ancillary activities. This includes occupants of LCC space and other departmental research space across
the institution, recipients of LCC philanthropic funds, and leaders of multi-investigator/multi-institutional grants or
clinical research contractual agreements. The Administration staffs all internal and external planning and
evaluation efforts, including meetings of the Program Leaders Committee, Scientific Research Council,
Executive Committee, EAB, and program and Center-wide retreats. It supports LCC membership, oversight of
shared resources, faculty recruitment, administration of pilot projects and internal research awards, oversight of
space and facilities and communications, such as website, newsletters and publications. The Administration
manages the $54 million annual budget, including grant, philanthropic, and other institutional funds; implements
Northwestern policy for the management of dedicated research and administrative space; coordinates new
member applications, and conducts the annual membership review and monitoring process; leads research
administration information technology, and prepares all CCSG documents and reporting.
Among the accomplishments of the administration over the current funding period, was the development of new
strategic plan through extensive work with Senior Leadership. By engaging over 250 stakeholders, and with help
of an outside consulting firm, this document contains key strategic goals focused on: 1) Delivering Exceptional
Care, 2) Advancing Medical Science and Knowledge, 3) Developing People, Culture, and Resources, and 4)
Expanding LCC’s reach and impact within Northwestern Medicine entities, throughout the LCC catchment area.
Other major LCC administration accomplishments over this grant period include significant contributions to the
restructuring of the basic science programs, development of new shared resources, recruitment of 88 new
faculty, renewal or new awarding of five large mult-PI grants, and multiple new initiatives to advance translation
of LCC research to clinical care. The efforts of the LCC administration demonstrably contributed to the 38%
increase in NCI funding over this grant period.